Cell-type and organelle-specific multi-omics platform for the study of brain aging

PROJECT SUMMARY
Interactions between different biomolecules, including proteins, lipids and metabolites, give rise to higher cellular,
tissue and organismal phenotypes and functions. Perturbation of these interaction networks is observed during
aging and in age-related diseases and identification of these changes can help identify contributing mechanisms.
This may be particularly valuable in case of complex diseases, such as late-onset Alzheimer’s Disease and
Related Dementias (AD/ADRD), with multiple contributing factors over a life span.
Biomolecule networks are affected not only by the overall abundance of individual components but also by
their distribution between specific cell types and localization to intracellular compartments. Although snRNA-seq
advances allow identification of cell-type specific gene expression patterns in many tissues including the brain,
cell-type and organelle-specific proteomic, lipidomic and metabolomic assessments remain challenging.
Additionally, integration of the various “omics” data and defining the influence of these changes on cellular, tissue
and organismal function presents an ongoing challenge. This poses a limitation, as understanding of disease
states requires consideration of interactions between different classes of biomolecules and associated pathways.
To address these challenges, we propose to develop an analytical multi-omics pipeline to identify cell-type
and organelle-specific functional relationships between different omics parameters and their effects on organellar,
cellular, tissue and organismal function during brain aging and in age-related neurodegenerative disease.
Consistent with their known contribution to brain aging and neurodegeneration, our initial focus will be on
interactions between lipid and protein networks specifically in mitochondria. We will use transgenic reporter mice
and optimize MS-based analytical approaches to determine cell-type (microglial and neuronal) specific changes
in mitochondrial lipidome and proteome and their influence on mitochondrial function during brain aging (AIM 1).
We will develop machine learning-based tools and workflows to allow integrated analysis of proteomic and
lipidomic data to generate testable hypotheses about mechanisms contributing to aging and to identify potential
novel intervention targets (AIM 2). Eventually the focus will be expanded to include other compartments
(lysosomes and lipid droplets) relevant to brain aging and AD/ADRD (AIM 3). Once established, our multi-omics
pipeline and tools will be made available to members of UMB, UMCP and other researchers interested in
understanding brain aging, neurodegeneration and other age-related processes.

Public health relevance
PROJECT NARRATIVE Interactions between different biomolecules, including proteins, lipids and metabolites, give rise to higher cellular, tissue and organismal functions. Perturbation of these interaction are observed during aging and in disease and can help identify disease mechanisms. We propose to develop an analytical multi-omics pipeline to identify functional relationships between different biomolecules and determine mechanisms contributing to brain aging and neurodegenerative diseases.